Novel strategy combined with targeted radiation therapy unleashes potentantitumor immunity in HPV + head and neck cancer

Project Summary/Abstract
The overwhelming public health burden of HPV-associated head and neck cancer (HNC) has created great
demand for novel, broadly effective therapies with reduced treatment morbidity and improved long term survival.
While targeting HPV antigens in HPV+ cancers may be intuitive, these strategies have not demonstrated clear
treatment efficacy, potentially due to the importance of neoantigen-specific cytotoxic T cell immunity in the long-
term control of all cancers, including viral-associated cancer (1). Devising an off-the-shelf, broadly effective
therapeutic strategy that can easily be combined with standard-of-care chemoradiation and is capable of
potentiating both HPV- and neoantigen-specific CD8+ T cell immunity in HPV-associated HNC could prove
widely efficacious. The generation of tumor-specific CD8+ T cell immunity requires potent antigen presentation
by dendritic cells (DCs) since tumor cells do not efficiently present relevant CD8+ T cell epitopes. Murine CD103+
and CD8a+ DCs (cDC1s) are known for their ability to process exogenous antigen and potently cross-present to
CD8+ T cells. Because of this, innovative strategies to enhance cross-presenting DC subsets could robustly
induce HPV- and neoantigen-specific immunity and have great therapeutic potential in the treatment of HPV-
associated HNC. FMS-like tyrosine kinase 3 ligand (Flt3L) is a cytokine that expands and differentiates DC
precursors to murine cDC1s, but therapeutic potential of Flt3L is limited because of its short half-life and global
distribution in vivo. We have overcome the described issues of Flt3L by generating a genetic fusion of Albumin
(Alb) to Flt3L, named Albumin-Flt3L (Alb-Flt3L). Alb has a long half-life due to neonatal Fc receptor (FcRn)-
mediated transcytolic recycling, and exhibits trafficking to the LNs as a serum protein. The novel
immunotherapeutic Alb-Flt3L fusion protein exhibits increased half-life and selective accumulation in LN and
tumor compared to native Flt3L. Alb-Flt3L is able to expand cross-presenting DC populations in vivo following a
single injection. Alb-Flt3L + targeted radiation therapy (RT) to release tumor antigens and enhance tumor
immunogenicity is able to control tumor progression and extend survival of colon adenocarcinoma MC38 tumor
bearing mice. Impressively, Alb-Flt3L + RT induced spontaneous tumor neoantigen-specific T cell responses, in
addition to efficacy as a single agent in PANC02 model. In this proposal, the ability of Alb-Flt3L to promote HPV-
and neoantigen-specific cytotoxic T cell antitumor immunity through the expansion of cross-presenting DCs and
subsequent tumor control in multiple HPV-associated HNC models will be investigated. HPV- and neoantigen-
specific CD8+ T cell responses will be evaluated using tetramer and TCR sequencing approaches. The
mechanism by which Alb-Flt3L mediates its immunostimulatory function will also be interrogated using
appropriate deficient mouse models. Successful completion of this proposal will generate valuable preclinical
and mechanistic data regarding the therapeutic potential of Alb-Flt3L, a novel immunotherapeutic with potential
efficacy as a universal strategy to treat HPV-associated HNC as well as many other types of cancer.

Public health relevance
Projective Narrative In the current proposal, utility of our novel immunotherapeutic fusion protein of Albumin and FMS-like tyrosine kinase 3 ligand named Albumin-Flt3L (Alb-Flt3L) in mediating tumor control through the expansion of cross- presenting CD103+ and CD8a+ DCs and subsequent generation of HPV- and neoantigen-specific antitumor cytotoxic CD8+ T cells will be investigated in two models of HPV-associated head and neck cancer. We will study how enhancing cross-presenting DCs using Alb-Flt3L augments T cell-mediated antitumor immunity and potential mechanisms by which Alb-Flt3L mediates its immunostimulatory function. The successful completion of this project will provide valuable preclinical and mechanistic data for future studies while delineating the therapeutic potential of enhancing cross-presenting DCs using Alb-Flt3L for the treatment of HPV-associated head and neck cancer.